Attacking the Tumor Cell-Immune Milieu Interface to Overcome Richter's Transformation

Abstract
The ability of cancer cells to progress and transform to more aggressive disease is the leading cause for failure
of cancer-directed treatment. This is the case in Richter’s transformation (RT), a devastating complication of
chronic lymphocytic leukemia (CLL). RT is associated with an overall survival less than 12 months. While
standard chemotherapy results in potent but transient cytolytic effects, novel targeted agents such as ibrutinib
are ineffective. The early promise of immunotherapy in RT (checkpoint inhibitors, T cell engagers) brings hope
to combinatorial targeted and immune therapy. This requires comprehensive understanding of the intrinsic
cellular pathways and extrinsic immune environment which coordinately drive CLL-to-RT transition. However,
lack of in vitro or in vivo models and limited understanding of the disease mechanism are the bottlenecks for
studying RT biology and designing better treatments.
To address this challenge, we focused on first building the resources to study this deadly malignancy. Wang
laboratory recently established a novel murine model that mimics CLL-to-RT transition based on silencing of
Mga to activate MYC pathway in an existing murine CLL model. Characterization of murine model revealed
significant metabolic changes during CLL-to-RT transition that are dependent on MYC and its target gene,
NME1. MYC is known to promote lymphomagenesis via driving oncogenic transcriptional programs and
modulating immune cells to promote lymphomagenesis. We demonstrated that targeting MYC via cyclin-
dependent kinase-9(CDK9) inhibitor is effective in a murine model of RT. Furthermore, Danilov laboratory
developed clinical trials (NCT03884998, NCT05168904, NCT03547115, NCT05665530) to examine
combination inhibitors to treat RT. Preliminary results revealed favorable response with downregulation of MYC
pathway in tumor cells and induction of the inflammatory immune environment. We hypothesize that definitive
therapies for RT can be achieved by concurrent targeting of intrinsic oncogenic pathways and modulation of the
immune milieu. Combined our expertise from disease mechanism (Wang) and clinical/translation research
(Danilov), we propose to determine MGA/MYC/NME1 regulatory axis in driving CLL-to-RT transition via
impacting cell-intrinsic properties (Aim 1) and extrinsic immune cell function (Aim 2), with a goal of exploiting
novel immunotherapy modalities using our newly established murine RT model and clinical samples from
ongoing clinical trials of immunotherapy and CDK9 inhibitors in RT and lymphoma.
Altogether, the proposed studies serve to decode key oncogenic pathways and characterize the immune cells
co-driving RT, reveal vulnerabilities and identify novel strategies to engage anti-tumor immunity, which is
anticipated to help the design of the next generation therapeutic approaches to conquer RT.

Public health relevance
PROJECT NARRATIVE Richter’s transformation (RT) is a progression of chronic lymphocytic leukemia (CLL) to aggressive lymphoma, and patients with RT have a dismal prognosis with median overall survival less than 12 months. We propose to examine how MGA/MYC/NME1 axis drives onset of RT through influencing tumor cells and the immune milieu, and determine whether combinational therapies targeting both tumor and immune cells are effective using murine model and primary samples from ongoing clinical trials. Results from this study is expected to design better therapeutic approaches to conquer RT.